Efficient, cost-effective, and ultrasensitive sequencing of somatic mutations and methylation

ABSTRACT
Next-generation sequencing (NGS) has become increasingly integral to the practice of clinical oncology,
where its ability to scalably examine hundreds to thousands of targets now routinely enables identification of
prognostic and therapeutically actionable markers that support the practice of precision medicine. There are
many applications for which it would be useful to detect and quantitate genetic and epigenetic cancer-associated
variants at ultra-low levels (<1 in 10,000 or more), such as identifying drug-resistance mutations in tumors,
detecting residual cancer cells after therapy, or early cancer detection. Nevertheless, standard NGS technologies
are hampered by a relatively high error rate (~1 in 100bp), below which true biological variation cannot be
distinguished from noise. Various methods have been proposed to bypass this issue by allowing error correction
of NGS sequence reads, but such techniques are limited by technical and economic considerations, and have
consequently seen little uptake in clinical use due to issues of cost-effectiveness, scalability, and practicality.
Separately, there remains an unmet need for approaches that are able to sensitively assess both cancer-specific
mutations and methylation profiles in a specimen using a single library preparation and sequencing run. We
have recently developed a new experimental paradigm that addresses the limitations currently presented by
error corrected sequencing techniques: we join the two strands of DNA from an initial template fragment into a
single, covalently linked molecule. Error correction of the duplex can be performed by comparing separate reads
from the two linked strands, thereby eliminating the need for redundant sequencing of template molecules. This
provides robust error correction with scalability, cost-effectiveness, efficiency, and quantitative precision, and is
compatible with low-to-mid output short read sequencing platforms (ie, Illumina) that are already in
widespread clinical use. The current proposal will expand functionality of our approach to simultaneously
detect DNA methylation patterns and cancer-associated mutations with ultrasensitivity. In our first Aim, we
will develop methods and supportive bioinformatic analysis pipelines in support of this technology, and will
characterize the cardinal performance metrics of the approach using reference material. In our second Aim, we
will apply our technique to detect disease-associated mutations and methylation markers that identify residual
tumor cells after leukemia therapy, the key prognostic variable predicting relapse. In the third Aim, we will
identify cancer-associated methylation and mutation signatures in cell-free DNA from prostate cancer patients
to improve cancer detection and monitoring. This work will provide information and deliverables having
immediate, direct, and transformative benefit to cancer patients by improving the quality of oncology
sequencing assays while imbuing them with enhanced diagnostic capabilities for the ultrasensitive detection of
cancer associated mutations and epigenetic changes through the use of a single assay.

Public health relevance
PROJECT NARRATIVE Next-Generation DNA sequencing is now widely used in clinical oncology to detect mutations in cancers that inform prognosis and therapeutic options, but is limited in its sensitivity for low-prevalence variants. This proposal outlines the development and validation of inexpensive, efficient, and ultrasensitive methods for detecting cancer-relevant mutations and methylation patterns in clinical specimens. This technology will be immediately translatable and practical for clinical diagnostics, and will provide enhanced capabilities in a broad range of applications, including the identification of emerging cancer subclones and ultrasensitive screening for the emergence or recurrence of malignancy.